Hyperphosphatemia Contributes to Cardiac Injury in Chronic Kidney Disease

PROJECT SUMMARY
Chronic kidney disease (CKD) is a health epidemic that increases risk of death due to cardiovascular disease.
Hyperphosphatemia and elevations in serum levels of the hormone fibroblast growth factor (FGF) 23 are a
hallmark of CKD and associated with an increased risk of cardiac injury and death. We previously found that in
rodents, hyperphosphatemia induced by the administration of a high-phosphate diet elevates serum FGF23
levels and causes cardiac hypertrophy in the absence of kidney damage, suggesting that elevated phosphate
and/or FGF23 per se might act as circulating factors that can damage the heart. However, whether phosphate
or FGF23 can directly target the heart and induce injury is unknown. FGF23 is mainly produced by bone, and
we previously found that FGF23 can activate specific signaling events in cultured cardiac myocytes and induce
hypertrophy. However, whether FGF23 can directly target cardiac myocytes in vivo remains unknown. Based on
global FGFR4 deletion and pharmacological FGFR4 inhibition studies, we have recently identified FGFR4 as the
FGF23 receptor that is required for the development of cardiac hypertrophy in animal models of CKD as well as
in mice on high-phosphate diet. For the proposed study we have generated a novel mouse model for the cardiac
myocyte-specific deletion of FGFR4. By inducing CKD via an adenine diet or by administration of a high-
phosphate diet, we will be able to determine whether FGF23/FGFR4 activation in the heart is required for the
development of cardiac injury. Furthermore, direct effects of phosphate on cardiac myocytes have not been
studied to date. Our preliminary work indicates that elevations of extracellular phosphate levels in cardiac
myocyte cultures induce pro-inflammatory signaling and osteogenic gene programs. Here we will determine
whether these changes lead to pathologic cardiac remodeling in mice, including cardiac hypertrophy, fibrosis,
inflammation and calcification. We also found that phosphate treatments of cultured cardiac myocytes induce
the expression of FGF23 that under normal conditions is not found in the heart. It has been reported that in CKD
the heart starts to produce FGF23. However, whether heart-derived FGF23 can cause cardiac remodeling, is
unclear. To determine the consequences of cardiac FGF23 production, we will generate a new mouse model
with cardiac myocyte-specific deletion of FGF23, followed by the administration of high-phosphate or adenine
diets, and a detailed analysis of cardiac structure and function. Overall, our study is designed to test the
hypothesis that hyperphosphatemia - by itself as well as in the context of CKD - contributes to cardiac injury by
inducing FGF23 production in the heart. FGF23 is a potent pro-hypertrophic factor, and like circulating FGF23,
paracrine FGF23 might directly target cardiac myocytes via FGFR4 and induce cardiac injury. We postulate that
pharmacologic blockade of FGFR4 can inhibit the pathologic actions of FGF23 on the heart and thereby serve
as a novel therapeutic strategy to prevent or treat CKD-associated cardiac injury and prolong survival.

Public health relevance
PROJECT NARRATIVE Patients with advanced chronic kidney disease (CKD) suffer from widespread tissue injuries and develop markedly increased blood levels of phosphate and fibroblast growth factor 23 (FGF23). We have experimental evidence suggesting that phosphate and FGF23 can directly target the heart and cause pathologic changes in cardiac structure and function. In this research proposal, we will determine how phosphate and FGF23 act on heart tissue and whether FGF23 made by heart muscle cells can cause CKD-associated heart injury, which would suggest that CKD patients might benefit from therapies tackling phosphate and FGF23.